Investigator Development Core

ABSTRACT
The BBRC RCMI proposes to create an Investigator Development Core (IDC), the purpose of which is to foster
excellence of BBRC RCMI investigators at all career stages, with a special focus on Early Stage Investigators
(ESI). The goals of the IDC will be to create a culture of mentorship, support and research excellence within the
BBRC RCMI, incentivize the submission of extramural grants by ESI, and to offer opportunities for BBRC RCMI
investigators to seek seed funding for pilot projects sponsored by the center. The innovative aspects of this
approach include (1) extending support to all BBRC RCMI investigators of any career stage; and (2) a “synergy
= success” model which incorporates the commitments of multiple stakeholders at the university, programmatic,
and external levels to ensure a sustained support of BBRC RCMI Investigators. Drawing from best practices and
lessons learned from fellow RCMIs that have identified and addressed key barriers to center success, the BBRC
RCMI proposes IDC activities to include: (1) mentorship of senior postdoctoral fellows and ESI, including
involvement of the NIGMS-funded National Research Mentoring Network (NRMN); (2) training on grant writing
for BBRC RCMI investigators; (3) course release offers to ESI in exchange for using the protected time to write
and submit proposals for extramural funding; (4) opportunities for ESI to compete for seed funds to jumpstart
efforts to secure preliminary data for preparation of larger competitive grant submissions; and (5) opportunities
for senior postdoctoral fellows and senior investigators to secure small-term starter or bridge funds, respectively,
at critical transition points in their research career. It is anticipated that the concerted investment of UTEP and
the BBRC RCMI at all levels of organization will succeed in creating a dynamic and productive workforce, sustain
a support structure throughout the career trajectories of early-, mid-, and senior-level investigators, and facilitate
the generation of outstanding research products that contribute to our understanding of minority health disparities
in the border region.